Examining Non-Congregate Shelter Effects on Mental Health Crises through Community Health Partnerships in Connecticut

PROJECT SUMMARY
People experiencing homelessness have a disproportionate burden of mental illness and mortality than those
who are not homeless. The environment in congregate shelter accommodation may significantly contribute to
this health burden, particularly regarding mental health. Housing insecurity significantly increases risk of
presenting to the emergency department in behavioral crises, especially for individuals who are Black and Latinx
as well as sexual and gender minorities. In response to public health concerns regarding the specific
vulnerabilities of this population to COVID, many cities implemented programs diverting congregate shelter
residents, most commonly to hotel accommodation. There is some evidence that the shift to non-congregate
living may have had a positive impact on people's mental health. Connecticut localities are planning new policies
designed to build on lessons learned from that period, providing non-congregate options through healthcare-
community partnership organizations to people who are unhoused. Understanding the mental health effects of
non-congregate shelter options is essential to inform these developing policy reforms and innovations.
This project will use a Community Based Participatory Research transformative approach, with a multistage
convergent parallel mixed methods design, to measure the impact of healthcare-housing community
partnerships that support non-congregate living interventions on mental health. We will conduct the study in
Connecticut, which received the most expansive eligibility standards in the nation and included diversion of the
state's entire homeless population to hotel rooms. This context presents an unprecedented opportunity to study
the relationship between shelter interventions and mental health outcomes. We will aim to study the impact of
both the above-mentioned shelter policies and developing and ongoing post-pandemic housing initiatives on
mental health crises by: 1) Qualitatively exploring mechanisms between non-congregate housing policies and
mental illness including a landscape analysis to characterize processes through which shelter and healthcare
providers partner to address housing needs, building on strong existing relationships with stakeholders and
people experiencing homelessness; 2) Characterizing the effect of Connecticut's hotel-based temporary shelter
program on mental health crises among patients experiencing homelessness who were diverted from congregate
shelters to hotel rooms during the COVID-19 pandemic compared to a control site in Alabama using data from
electronic medical records to perform a difference-in-differences identification strategy; and 3) Prospectively
evaluating, using mixed methods, the impact of post-pandemic housing policies that offer non-congregate living
options on mental health, including non-congregate spaces in existing shelters, and newer potential policies such
as tiny house villages. Findings from this study have the potential to inform policies and procedures of healthcare-
housing community partnerships and improve mental health among those experiencing homelessness.

Public health relevance
PROJECT NARRATIVE This project will contribute to our understanding of the ways in which non-congregate forms of housing shelter may improve the mental health outcomes of people through service delivery by healthcare-community housing partnerships. Traditionally, shelter options provided for this population have been congregate, but during the early years of the COVID-19 pandemic, congregate shelter residents were moved to non-congregate spaces like hotels to minimize the spread of the disease. As those policies expand and evolve, it is essential that we learn about the impact they had on mental health, to inform future housing policies.